NHGRI Research Training and Career Development Annual Meeting

Summary
The National Human Genome Research Institute (NHGRI) provides support for trainees from the
undergraduate to the post-doctoral level in the fields of genome sciences, medicine and ethical, legal and
social implications. The annual meeting is a venue for NHGRI trainees to present their research and learn
about other research and programs, to network and begin to develop collaborations with other trainees and
faculty, and gain experience of attending professional scientific conferences (this will be the first professional
meeting for some trainees). Through this award, we will provide continued support for this excellent annual
event for trainees and strive to enhance the impact, learning efficiency and networking opportunities with new
and innovative technologies to address the changing landscape, in part brought on by COVID19. These will
include a meeting app, quarterly virtual meetings, a virtual mentorship platform, and career development
opportunities. Specifically, we will provide pre- and post-meeting support as well as onsite support during the
meeting. To inform meeting planning and ensure that meeting activities are responsive to trainees’ needs and
interest, we will establish a planning advisory committee to work with us throughout the year, comprised
primarily of trainees. We will work closely with program staff on details regarding meeting location, structure,
and agenda. In light of the novel coronavirus and societal events regarding race and justice, facilitating regular
connections between trainees, faculty, and program staff can yield multiple benefits to maintain momentum in
research and training, personal well-being, and attainment of career goals and higher education. Through the
virtual quarterly meetings, we aim to help reduce the impact and burden of the upheaval and uncertainty in the
research and academic environment due to current events on trainees’ progress as well as their health and
well-being, foster additional mentoring and peer support, and identify areas where new interventions and
support are needed. In addition to providing a platform to discuss research and training opportunities, we
aspire to develop a culture of support and build a web-based resource for trainees in the genome community to
recognize trainees’ achievements and provide information regarding employment, training, and educational
opportunities. Overall, these changes will optimize the efficiency and productivity of the annual in-person
meeting, provide flexibility and sustain relationships formed at the in-person meeting as well as foster new
ones to provide networking opportunities and peer support.

Public health relevance
Public Health Relevance This proposal will provide support to plan and coordinate the NHGRI Research Training and Career Development Annual Meeting. The annual meeting provides an excellent opportunity to showcase trainees’ work through poster and platform presentations, to provide the experience of a professional scientific meeting, and to network. These annual meetings provide trainees with a valuable learning opportunity and platform for their educational advancement and career growth for the next generation of genome scientists and providers.